Implementing A QSP Platform to Predict and Test Drugs for Metabolic Associated Fatty Liver Disease Genetic Variants in an iPSC-cell Based Human Biomimetic Liver Microphysiology System

Project Summary:
Nonalcoholic fatty liver disease (NAFLD), recently renamed metabolic dysfunction associated fatty liver
disease (MAFLD), is a worldwide public health problem. Despite major investments by the pharmaceutical
industry, there are no approved drugs for the treatment of MAFLD, reflecting the heterogeneous
pathophysiology of this disease. We have implemented a platform focused on a human vascularized liver
acinus microphysiology system (vLAMPS) biomimetic that incorporates four human liver cell types and uses
genomic, biochemical, and phenotypic metrics, and quantitative systems pharmacology (QSP) to identify
mechanisms of disease progression that can be used to inform new or repurposed drugs for MAFLD. Genome-
wide association studies (GWAS) have identified several variants that are associated with MAFLD
susceptibility, including mutations in PNPLA3, TM6SF2, and MBOAT7. In contrast to these variants that
increase MAFLD risk, recent studies have identified two novel protective variants, HSD17B13 and MTARC1,
that are linked to lower risk of MAFLD. However, little is currently known regarding the biological function of
these protective variants. Thus, our goal is to harness the computational and experimental QSP platform with
genome-edited iPSC-derived liver cells to experimentally test probe drugs and drug combinations predicted by
computational analysis to normalize key disease phenotypes and to provide mechanistic insight into the role
novel protective variants have in both alleviating MAFLD progression and as attractive new pharmacological
targets; thus, linking specific genetic variant risk factors with successful intervention on druggable pathways.
We will test the following Specific Aims: (1) Implement optimized biomimetic vLAMPS to recapitulate both
normal liver function and MAFLD disease progression using iPSC-derived liver cells harboring clinically
relevant variants (2); Test the response to drugs predicted to halt or reverse MAFLD disease phenotypes using
iPSC-derived high-risk variants in vLAMPS; (3) Test the response to drugs predicted to halt or reverse MAFLD
disease phenotypes using iPSC-derived high-risk variants in vLAMPS.
The lack of approved drugs for treatment of MAFLD is due to the heterogenous pathology of disease
progression and the limitation that animal models do not fully recapitulate the human disease. The use of a
combined QSP and iPSC-derived MPS experimental platform to examine mechanistic detail of key disease-
related genetic variants and to use for testing predicted drugs serves as a starting point to identify optimized
therapeutics that will advance the approach to MAFLD drug discovery.

Public health relevance
Project Narrative: The lack of approved drugs for treatment of MAFLD is due to the heterogenous pathology of disease progression and the limitation that animal models do not fully recapitulate the human disease. The use of a combined QSP and iPSC-derived MPS experimental platform to examine mechanistic detail of key disease- related genetic variants and to use for testing predicted drugs serves as a starting point to identify optimized therapeutics that will advance the approach to MAFLD drug discovery. The more detailed analysis of the best drugs and drug combinations in an optimized biomimetic model will refine the selection of drugs/combinations for select patient cohorts.